Aging in Puerto Rico: Longitudinal Follow-Up of the PREHCO Study

PROJECT SUMMARY/ABSTRACT
In the past decade, Puerto Rico has experienced rapid population aging, financial collapse, mass outward
migration of younger people, and then Hurricane Maria. Now is an ideal time to build on the only population-
based cohort of older adults in Puerto Rico, unique in having data on health and function prior to these major
events. Households across Puerto Rico were visited to identify the first island-wide sample of adults age 60+
years for the Puerto Rican Elderly: Health Conditions (PREHCO) study. A wide range of measures relevant to
health and aging, including in-home testing of cognitive and physical function, was collected at baseline
(2002/2003) and four years later (2006/2007). We propose to gather two new waves of data related to aging,
stress and health in a sample of approximately 1,000 PREHCO survivors. The current project will a) extend
PREHCO follow-up to between 16 and 20 years after baseline; b) examine life course predictors of major aging
outcomes, namely cognitive impairment, disability, and mortality; c) collect data on hurricane-related stressors
and mental health; d) add hair cortisol as a marker of chronic hypothalamic pituitary adrenal (HPA) axis
activation; and e) add cognitive and proxy informant measures that align with the Health and Retirement Study
(HRS). Our project will enable the following specific aims: Aim 1. Examine longitudinal life course
biopsychosocial predictors of cognitive health, cortisol levels, mental health, disability, and mortality 16-20
years after baseline. Aim 2. Examine cross-sectional associations between stressors, resilience-enhancing
factors, perceived stress, cortisol, and health, as well as changes in health two years later. Aim 3. Increase
utility of PREHCO for cross-cultural comparisons. Puerto Rico is an important part of the U.S. that has largely
been omitted from U.S. population-based studies of aging. PREHCO participants are now age 76+ years and
given accelerating mortality rates for this age group, our proposal to gather two new time points of follow-up
data for PREHCO represents a time-limited opportunity to add to our knowledge about aging, stress, and
health in an understudied and potentially vulnerable population.

Public health relevance
PROJECT NARRATIVE We propose to gather two additional waves of data for the first and only population-based study of older adults in Puerto Rico, extending follow-up to between 16 and 20 years. This sample is unique in having information on key characteristics relevant to health and aging from over a decade ago, before many of the adversities that people in Puerto Rico are now facing. Our findings can serve to identify and target areas of greatest need to maintain health and quality of life among older Puerto Ricans without overextending government resources, which are most likely to continue to be limited.